Structural insights into the Argonaute-containing CDK8 complex

Abstract
In eukaryotes, transcription Mediator contains a dissociable Cdk8 kinase module (CKM) that regulates gene
expression through kinase-dependent and -independent functions. The human CKM consists of Med13,
Med12, Cdk8, and CycC subunits, which are either mutated or amplified in neurodevelopmental disorders and
multiple cancers, such as breast and colorectal cancers. Despite extensive links between CKM and human
diseases, the fundamental mechanisms of CKM in regulation of gene transcription remain poorly understood.
The long-term goal is to elucidate the molecular mechanisms by which CKM regulates gene transcription
through its kinase function and nucleic acid interactions. The overall objectives in this application are to (i)
reveal the structure basis and functional roles of CKM subunits, (ii) elucidate the activation mechanism of Cdk8
and the way in which it recognizes substrates for phosphorylation, and (iii) investigate the functional
interactions between Med13 and nucleic acids. Three aims are proposed in this application. Aim 1 is to
uncover the high-resolution structure of yeast CKM and understand how Cdk8 becomes activated by Med12
and binds substrates. We will use single-particle cryo-EM to reveal
interactions
how
the
targets
the overall structure of yeast CKM and its
with Cdk8 substrates. We will use biochemical approaches to elucidate the detailed mechanism of
Cdk8 kinase is activated by Med12 through a non-canonical mechanism. In Aim 2 , we will characterize
nucleic acid binding properties of Med13 using biochemical approaches as well as identify its binding
using next-generation sequencing. In Aim 3, we willuse our detailed knowledge of yCKM to reinforce
our knowledge gained from studies of human CKM's structure, substrate binding, and disease mutations.
proposed
kinase
regulation
The
studies are significant because they will provide valuable structural and functional insights into the
function and nucleic acids interaction of CKM revealing the fundamental mechanisms of CKM in
of gene expression. Ultimately, our results will offer
,
a structural foundation for development of
kinase inhibitors to treat Cdk8-driven human diseases.

Public health relevance
Project N arrative Dysregulation of gene expression driven by aberrant kinases can cause many diseases. The CDK8 complex, which consists of 4 transcription Mediator proteins, was found mutated in human diseases such as neurodevelopmental disorders and cancers. In this project, we will investigate the structure and function of the CDK8 complex, which is expected to provide crucial clues for the development of new strategies for disease treatment.